CSHL 2016 Neuronal Circuits Conference

? DESCRIPTION (provided by applicant): This proposal seeks support for the meeting on Neuronal Circuits: from Structure to Function to be held at Cold Spring Harbor Laboratory April 6 - 9, 2016. The meeting will assemble leaders in the field, together with junior faculty, postdoctoral fellows and graduate students, to discuss the latest advances that analyze structure and function of nervous systems on the level of neuronal circuits in a variety of organisms and systems. Computation in neuronal circuits is perhaps the major unresolved problem in biology and provides a missing link between genes and behavior. We believe that the problem of such magnitude requires joint efforts among scientists working on different organisms and systems. Creating such synergy served as a motivation for starting this biannual meeting series. By now, this is a well established and highly regarded in the community meeting, which has an unusual inter-species flavor and focus on circuit structure and function. By its very nature, research presented in the meeting is highly interdisciplinary as it brings together experimentalists, theorists, engineers and researchers from a range of quantitative disciplines. The meeting will include sessions on sensory processing, plasticity, behavior, basal ganglia, active sensing, and technological innovations & applications. Each session will be chaired by a leading scientist in the field. Oral presentations will be given be a group of distinguished invited speakers as well as selected from submitted abstracts by the meeting organizers. Selected speakers will include graduate students, postdoctoral fellows and junior faculty aiming for maximal inclusion of young investigators. Of special importance is the poster session, to be held in the new purpose-built Nichols-Biondi Hall, where many participants can present their work in an atmosphere conducive to informal discussion. The meeting will be of moderate size and we expect about 250 people to attend, the vast majority of whom will be presenting a poster or talk.

Public health relevance
PUBLIC HEALTH RELEVANCE: The human brain is often compared to a computer because of its computational abilities. However, unlike computers, whose operation can be understood using wiring diagrams and logical flowcharts, no similar circuit-level framework for the brain is available. What elementary circuit computations are performed by neurons? How much information does the wiring diagram contain? What other information is necessary to describe behavior? What physiological and genetic methods can provide such information? Traditionally, these questions are addressed in specific organisms and systems. Yet, it is likely that the answers are similar across various organisms. Therefore, researchers working on different organisms must benefit by interacting with each other and exchanging their results. To provide a venue for such interaction and exchange, we propose to hold a meeting entitled Neuronal Circuits: from Structure to Function at Cold Spring Harbor Laboratory in April 2016. This meeting will bring together experimentalists working on various systems and organisms, theorists, engineers and researchers from a range of quantitative disciplines to discuss cutting edge approaches and findings in this field.